Targeting Nell2 and GABAergic Dysfunction to Mitigate APOE4-Driven Pathogenesis in Alzheimer's Disease

PROJECT SUMMARY
The complexity and multifactorial nature of Alzheimer’s disease (AD) pose unique challenges for mechanistic
studies and developing therapies. Apolipoprotein (apo) E4, the major genetic risk factor for AD, lowers the age
of disease onset in a gene dose–dependent manner. In most clinical studies, APOE4 carriers account for 60–
75% of AD cases, highlighting the importance of APOE4 in AD pathogenesis. Longitudinal studies show that
APOE4’s detrimental effect on cognition depends on age and occurs before typical signs of AD arise. APOE4
has been linked to subclinical epileptiform activity during stress, and APOE4 carriers have increased
hippocampal activity at rest and in response to memory tasks, the extent of which predicts future memory decline.
Reducing hippocampal hyperactivity with the antiepileptic drug levetiracetam improved cognition in amnestic
mild cognitive impairment (MCI) patients and in AD mouse models, confirming that network hyperactivity
promotes AD-related cognitive dysfunction. Challenges in AD research are to fully understand how APOE4, sex,
and aging interact in a cell type-specific manner to contribute to AD pathophysiology, and what factors determine
individual neuron’s susceptibility or resilience to disease. Our published and preliminary data show that from a
young age, female APOE4 knock-in (E4-KI) mice exhibit region-specific hippocampal network hyperexcitability,
which predicts learning and memory impairment in old age. This early network pathology is driven by cell type-
specific effects of neuronal APOE4 and depends on the growth factor and intracellular signaling protein Nell2,
leading to the atrophy and hyperexcitability of vulnerable hippocampal excitatory neurons. Consequently, early
network hyperactivity results in the progressive and sex-dependent impairment and death of susceptible APOE4-
expressing hilar inhibitory interneurons, ultimately culminating in network failure and cognitive impairment in old
age. This proposal aims to (1) investigate the mechanism of action and validate the protective network and
behavioral outcomes of Nell2 deletion in hippocampal excitatory neurons of E4-KI mice, and (2) examine the
transcriptomic and molecular mechanisms of APOE4-, sex-, and age-dependent dysfunction and selective
vulnerability of inhibitory interneurons. We will use a multi-level approach with cutting-edge methods, from single-
nucleus RNA sequencing from individual neurons with CRISPR-based target validation, to in-vivo brain activity
recording and behavioral testing. The outcomes of the proposed study will provide crucial insights into the
mechanisms behind selective APOE4-induced neuronal dysfunction and help identify potential therapeutic
targets for mitigating age- and sex-dependent cognitive decline in Alzheimer's disease.

Public health relevance
PROJECT NARRATIVE The E4 variant of the APOE gene (APOE4) is the strongest genetic risk factor for developing Alzheimer’s disease (AD). This project aims to uncover the mechanisms underlying how APOE4 affects different cell types and subpopulations in the brain. The proposed studies will reveal how APOE4 drives AD pathogenesis and will facilitate the development of targeted treatment strategies for individuals at risk for AD.